Core--Flow cytometry

The Flow Cytometry Facility is a shared resource available to all UICC investigators. The overall goal of the Flow Cytometry is to provide investigators with the ability to analyze and sort cell populations using multiple parameters for a broad range of research applications. Consultation is provided as needed with the Director, Technical Director, and other support personnel. Specifically, the facility: 1) Provides advice and technical expertise for analysis and/or separation of cell population based upon their ability to bind fluorochrome conjugated antibodies. 2) Aids investigations in the use of the FACS IV and Epics 753 flow cytometers for analysis (FACS IV and EPICS) and sorting (Epics) for cell populations. 3) Trains investigators and their laboratory personnel in the use of the FACSCAN for analysis of cell populations. 4) Trains and assist investigators in the use of the facility's computers for the analysis and output of data accumulated during the flow of cytometry studies. 5) Aids investigators in the use and/or development of new fluorochromes for analysis of cells populations.